Polycomb Repressive Complexes and Chromatin Architecture in Cellular Aging of the Brain

Abstract
Aging is accompanied by complex, cell type-specific epigenetic alterations, yet the impact of these changes on
the dysregulation of cellular transcriptomes and functional decline remains poorly understood. Among key
epigenetic modulators, Polycomb Repressive Complex 1 (PRC1) maintains gene silencing by establishing a
repressive chromatin environment. Previous studies demonstrated that PRC1 complexes inhibit cellular
senescence, indicating a potential role of PRC1 in aging. Mechanistically, PRC1 antagonizes senescence by
repressing its target gene, CDKN2A, which encodes the CDK inhibitors p16Ink4a and p14Arf. Later research
revealed reduced expression of Pcgf4, a key component of PRC1, in the aged brains of both humans and mice.
Mice with a heterozygous deletion of Pcgf4 develop normally, but they show cognitive deficits and
neurodegeneration during aging. Although PRC1 loss strongly correlates with brain aging, the extent to which
PRC1 exerts cell type-specific effects is not fully understood. A significant barrier to understanding the role of
PRC1 in aging is the cellular heterogeneity within brain tissues, which complicates in vivo studies of protein-
protein and protein-chromatin interactions. To address this challenge, we have recently developed a
biotinylation-mediated lineage-specific capture (BLINC) technique, enabling us to define PRC1 composition and
function in defined brain cell types. Our overarching goal is to elucidate how PRC1 regulates chromatin
environments and maintains cellular transcriptomes during brain aging. We will address this through two specific
aims. Aim 1: Using BLINC, we will identify PRC1 composition and chromatin modifications across various brain
cell types in young and aged mice. Leveraging BLINC with Affinity purification, mass spectrometry, and deep
sequencing, we will reveal how PRC1-mediated chromatin changes contribute to age-related alterations in gene
regulation. Aim 2: We will examine the functional consequences of PRC1 loss in glutamatergic cortical neurons
using conditional knockout models. By assessing chromatin and transcriptomic changes in these neurons, we
aim to uncover mechanisms by which PRC1 prevents age-associated shifts toward a pro-senescence state. By
combining BLINC with proteomic and genomic analysis, our study will provide novel insights into PRC1
regulation on chromatin dynamics during aging, which may lead to novel therapeutic targets for age-related
conditions.

Public health relevance
PROJECT NARRATIVE Epigenetic alteration is a hallmark of aging, yet the mechanisms with which it drives cellular functional decline remain poorly understood. We propose to study how PRC1 complexes, important epigenetic modulators, maintain healthy cellular epigenetic environments and transcriptional programs in the brain using a newly developed in vivo cell type-specific capture technique. We expect this endeavor to advance our knowledge regarding the epigenetic mechanism(s) regulating brain aging and contribute to understanding its deregulation leads to neurodegenerative disorders.